Investigating the role of stromal YAP activation in intrahepatic cholangiocarcinoma

Project Summary/Abstract
Intrahepatic cholangiocarcinoma (ICC) is the second most common form of liver cancer and is often
diagnosed at an advanced or metastatic stage. The only available treatment for unresectable, late-stage ICC is
systemic chemotherapy which typically extends patient survival by less than two years. A hallmark of ICC is its
dense tumor reactive stroma (TRS), consisting of recruited endothelial cells, macrophages, and myofibroblasts
(MFs) from the surrounding liver. The TRS has been implicated in ICC tumorigenesis, and in particular a TRS
with more activated MFs is associated with a worse prognosis. Another hallmark of ICC is its heterogeneity,
with no oncogenic mutations common to the majority of patients. However, Yes Associated Protein (YAP), the
major downstream effector of the Hippo signaling pathway, has been shown to be activated in the majority of
human ICC tissue samples. Our lab has developed a novel syngenic mouse model of transplanted ICC, where
mouse biliary cells were isolated, cultured as liver organoids, and mutations found in human ICC patients were
introduced using CRISPR technology to generate ICC organoids. These ICC organoids can be transplanted
subcutaneously or intrahepatically to give rise to ICC tumors which recapitulate key features of the human
disease, including the recruitment of a dense TRS. Interestingly, we have observed the highest YAP activity in
the MFs of the TRS as opposed to ICC tumor cells in our model. Thus, we hypothesize that YAP activation in
the TRS is crucial for ICC tumorigenesis. We propose to test this hypothesis through deletion of YAP in the
TRS, as well as deletion of YAP specifically in TRS MFs, which we hypothesize will reduce ICC tumor burden
in our in vivo mouse model. To elucidate the mechanism of YAP-driven TRS MF and ICC cell crosstalk, we will
develop a novel ICC organoid and TRS MF in vitro co-culture system, where we hypothesize that TRS MFs will
promote ICC cell growth and invasion in a YAP-dependent manner. Finally, we will perform single-cell RNA
sequencing on control and YAP-deleted TRS MFs to identify YAP-driven secreted ligands in these cells. We
will then perform in our ICC organoids a CRISPR-Cas9 screen targeting the receptors corresponding to our top
secreted ligand hits in the TRS MFs. This CRISPR-Cas9 loss-of-function screen will be performed in our in
vitro co-culture system, and we will thus be able to identify the signaling pathways that mediate crosstalk
between TRS MFs and ICC cells. The pathways identified in our screen can be validated in our in vivo ICC
mouse model, increasing the validity of our findings. This work will not only identify molecular mechanisms of
crosstalk between ICC tumor cells and its associated liver stromal cells, but will identify new therapeutic targets
which could be investigated for novel ICC treatment strategies.

Public health relevance
Project narrative Intrahepatic cholangiocarcinoma (ICC) is an incurable, deadly form of liver cancer for which YAP, the major downstream effector of the Hippo signaling pathway, has been proposed to be an oncogenic driver. Our lab has identified a role of YAP signaling in the stromal cells surrounding ICC in driving tumorigenesis, and we propose to elucidate the mechanisms of YAP-driven signaling crosstalk between the stromal and ICC tumor cells. Our findings could identify new pathways which promote tumor growth and provide the basis for desperately-needed new treatment strategies for ICC.